Gene regulatory programs driving metabolic maturation ofhuman pluripotent stem cell derived beta-cells

PROJECT SUMMARY
Type 1 diabetes (T1D) is characterized by autoimmune destruction of insulin-producing β-cells in the pancreatic
islets. Several theories have been proposed to explain T1D pathogenesis including aberrant immune cell activity
as well as increased β-cell sensitivity to inflammatory and metabolic stressors. It has become increasingly
apparent that β-cells may not be passive immune cell targets but can contribute to the disease intrinsically.
However, it remains unclear whether the risk of developing T1D is already introduced during β-cell formation.
Postnatal β-cell maturation may be a T1D relevant β-cell developmental process, not only because it occurs
during the peak incidence of T1D diagnosis but also because it determines whether an individual has an
adequate functional β-cell pool to cope with environmental stressors. However, the mechanisms underlying
human β-cell maturation have been understudied due to the absence of an appropriate human β-cell model.
While human pluripotent stem cell (hPSC)-derived β-cells (SC-β-cells) hold immense potential for modeling T1D,
current production methods do not permit proper functional maturation, hampering their utility in studying β-cell
maturation. One of the hallmark features of mature β-cells is glucose-induced mitochondrial respiration, which is
lacking in SC-β-cells. It has been suggested that environmental cues, such as nutrients and circadian rhythm,
drive β-cell maturation and establish a mature β-cell state through gene expression regulation and epigenetic
modifications. Our objective is to uncover gene regulatory mechanisms that underlie the acquisition of glucose-
dependent mitochondrial function in human β-cells and assess the suitability of SC-β-cells as a model for
studying β-cell maturation. This work will leverage the genomic and genetic methodologies that we have
previously developed for SC-β-cells, including a platform for genome-wide functional perturbation screening,
single-cell genomics assays, and a computational tool to infer gene regulatory networks. Expanding on our
preliminary studies, we propose to investigate and modify key transcriptional programs governing SC-β-cell
mitochondrial activity and induce maturation in vitro (Aim 1). Mechanistically, we plan to investigate the
correlation between changes in SC-β-cell function and the epigenome that occurs during the maturation process
(Aim 2). It has been established that SC-β-cells exhibit improved function following engraftment into mice. Thus,
in the second aim of our study, we will also investigate epigenetic alterations that occur during this in vivo
maturation process. We anticipate that our in vitro manipulation of key transcriptional programs will induce similar
epigenetic remodeling as observed in vivo. Together, our proposed study will advance the culture of SC-β-cells
and demonstrate their utility as a model for investigating human β-cell maturation.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is characterized by massive β-cell loss due to autoimmune destruction. The generation of pancreatic β cells derived from stem cells (SC-β-cell) holds great promise for cell replacement therapy for T1D patients, and may serve as a disease model to facilitate the discovery of new therapies. This research will improve SC-β-cells produced in the dish by correcting how these cells utilize glucose in their mitochondria, a key process mediating insulin secretion.